EFFICACY AND SAFETY OF ARTZ IN TREATMENT OF OSTEOARTHRITIS OF THE KNEE

The primary objective of this multicenter, randomized clinical study is to determine the optimum number of intraarticular injections of ARTZ (sodium hyaluronate) as a treatment for the relief of pain in patients with mild to moderate osteoarthritis of the knee. The secondary objective is to evaluate efficacy and safety of ARTZ.